Habenular immune signaling and addiction

Medial habenula (mHb) neurons that project to the interpeduncular nucleus (IPn) regulate the “set-point” for
nicotine aversion and play a critical role in regulating nicotine intake. Nevertheless, little is known about the
consequences of nicotine consumption on the function of this circuit. We have collected compelling preliminary
data in rodents showing that nicotine reduces habenular volume, induces loss of mHb cholinergic neurons, and
triggers degeneration of projection fibers from mHb to IPn. We detect similar reductions of habenular volume in
human cigarette smokers compared with non-smokers. Selective lesion of the habenula-IPn circuit markedly
increases nicotine intake in rats, suggesting that nicotine-induced damage to the habenula-IPn circuit is likely
to increase the motivational significance of the drug. Uniquely, neurons in the mHb express interleukin-18 (IL-
18), a cytokine that regulates the function of microglia and other components of the innate immune system.
Microglia are known to control the strength of excitatory and inhibitory transmission by pruning neurons and
synapses to sculpt circuits in the brain. We find that nicotine has greater stimulatory effects on the habenula-
IPn circuit of Il18-/- mice than wild-type mice. Preliminary findings suggest that nicotine induces far greater
damage to mHb neurons in Il18-/- mice than wild-type littermates. Finally, Il18-/- mice demonstrate lower
numbers of microglia and reduced levels of microglia-derived cytokines in the habenula than wild-type mice.
Based on these findings, we hypothesize that nicotine triggers habenular degeneration and that IL-18,
produced by habenular neurons, protects against this response. We further hypothesize that IL-18 acts by
recruiting local microglia to prune habenular neurons, thereby opposing the excitatory actions of nicotine on
these cells. Here, we will use state-of-the-art molecular, cellular and behavioral approaches to test these
hypotheses. In Specific Aim I, we will use iDISCO tissue clearing coupled with light-sheet microscopy for super
3D resolution to fully characterize the role for IL-18 and microglia in regulating excitotoxic effects of nicotine on
mHb neurons. In Specific Aim II, we will investigate the role for which IL-18 and microglia in regulating the
stimulatory actions of nicotine on mHb neurons. In Specific Aim III, we will investigate the relevance of nicotine-
induced damage to the mHb, and the involvement of IL-18 and microglia in this process, to the motivational
properties of nicotine. This highly innovative program of research may yield fundamental new insights into the
links between brain immune function, habenular plasticity and nicotine addiction.

Public health relevance
Tobacco dependence is a leading cause of premature death and disease in the United States. Our laboratory has shown that medial habenula neurons plays a critical role in regulating the motivational properties of nicotine. In new findings, we show that nicotine has highly selective excitotoxic effects on these same neurons. Here, we will use cutting-edge molecular, cellular and behavioral approaches to investigate the mechanisms by which nicotine damages habenula neurons and determine the motivational significance of this effect. This program of research promises to identify entirely new classes of targets for the development of therapeutic agents for tobacco dependence and may therefore have a significant positive impact on human health.